Understanding SCA1 pathogenesis in human cerebellar organoids

PROJECT SUMMARY/ABSTRACT
Spinocerebellar ataxia type 1 (SCA1) is a dominantly inherited lethal neurodegenerative disease caused by 39-
82 CAG repeats in the ATAXIN-1 (ATXN1) gene. Patients with SCA1 suffer from progressive gait and balance
deficits, and severe degeneration of Purkinje cells (PCs) in the cerebellum. There are no effective disease
modifying therapies currently available for SCA1, indicating a critical need for better understanding of disease
pathogenesis.
Studies using limited postmortem brain tissue from patients are complicated by practical and ethical concerns
of tissue availability, late disease stage with the loss of neurons, and manipulation. Mouse models of SCA1
have been extremely useful in increasing our understanding of SCA1, but have important limitations due to the
inherent species differences as well as genetic modifications, such as overexpression and much longer CAG
expansions than seen in patients, needed to model disease.
Because of these limitations, we propose to complement studies using mouse models with the investigations of
human cells, including models of the human cerebellum. Recent study developed a robust and reproducible
protocol to generate human cerebellar organoids from iPSCs. We propose to use this protocol and our iPSCs
lines from SCA1 patients and sibling controls to establish a human cerebellar organoid model of SCA1. This
human cerebellar organoid SCA1 model will enable us to determine how ATXN1 with CAG expansions
commonly seen in patients impacts human cerebellar cells and cerebellar activity, as well as provide a platform
to help identify and test molecular targets for intervention.

Public health relevance
PROJECT NARRATIVE Currently, very little is known about the disease pathogenesis in human cerebellar cells in any of the spinocerebellar ataxias (SCAs), including SCA1. The research described in this proposal will fill these gaps in our knowledge by establishing a novel human cerebellar organoid model of SCA1 using iPSCs lines derived from patients and unaffected sibling controls.